Microfluidic Assays for Probing Neutrophil-Borrelia Interactions in Blood during Acute Lyme Disease

Lyme disease (LD) is caused by infection with Borrelia burgdorferi (Bb) and represents a growing problem in
the United States due to increasing prevalence and expanding geographic range. It is estimated that 300,000
cases of LD occurred in the United States in 2017. The disease course is highly variable and can include
organ-specific and disseminated involvement with acute and chronic manifestations. A knowledge gap exists
regarding the immune events during the dissemination of Bb in blood during acute LD. Our objective is to
bridge this knowledge gap through the development of novel tools that measure neutrophil-Bb interactions in
blood. In preliminary work, we demonstrate the feasibility of microfluidic assays for the study of host-pathogen
interactions in blood. Specifically, we found (A) a neutrophil spontaneous motility phenotype after spiking as
few as one hundred Bb in blood, (B) a similar phenotype in blood samples from acute LD patients, and (C) a
key role for complement in the activation on neutrophils in blood during early interactions with Bb. Continuing
these efforts, we will optimize the neutrophil-assay-design to (1) study the interactions between neutrophils and
live, motile Bb at single-cell resolution (2) identify signature neutrophil responses to Bb, and (3) probe the relay
function of neutrophils during complement activation in blood by small numbers of Bb. We will begin applying
the new tools to measuring neutrophil functions in patients during acute LD before specific antibodies are
produced, and during treatment, to evaluate the Bb clearance from blood. Overall, our study will design new
tools for the diagnostic and monitoring of LD and will expand our knowledge of host responses to LD.

Public health relevance
Lyme disease (LD) is a growing problem in the United States due to increasing prevalence and expanding geographic range. A major challenge for understanding how neutrophils interact with Borrelia burgdorferi, the spirochete causing LD, during the dissemination phase in the blood, is the lack of neutrophil analysis tools that work with blood. Recent observations, enabled by microfluidic devices, revealed that neutrophils in blood change their phenotype in the presence of as few as one hundred Borrelia spirochetes and point towards unexpected opportunities for advancing LD science, as well as towards new assays for early diagnostic and monitoring of LD patients.